2023 Assisted Circulation Gordon Research Conference and Seminar

Project Summary – The Gordon Research Conference (GRC) on Assisted Circulation is a bi-annual meeting
consisting of a diverse group of invited speakers, discussion leaders, and participants who are internationally-
recognized clinicians, engineers, and scientists pioneering the field of mechanical circulatory support (MCS)
and related disciplines. Our GRC program committee has developed a one-week program in preparation for
our next GRC on Assisted Circulation to be held in in Waterville Valley, New Hampshire from May 28 - June 2,
2023. The focus of our comprehensive GRC program is on the latest emerging developments in the MCS
field, including the presentation of previously unpublished data, clinical and scientific evidence-based research
and development activities, and introducing novel concepts that impact the future of MCS therapy and are
designed to improve heart failure (HF) patient outcomes and restore their quality of life. Invited speakers are
pioneers in the MCS field and related disciplines that will present their ground-breaking research and
development in critical areas of need. Discussion leaders will promote and actively engage audience
participation to encourage open and interactive exchange of concepts and ideas that are provocative and
stimulating to facilitate and rapidly accelerate advancement of MCS therapy. GRC participants will be
comprised of multi-disciplinary (clinical, engineering, science), multi-institutional (academic, industry, hospital,
government), and multi-diversity (career-stage, ethnic, gender, geographical) participants adjudicated by GRC
and Program Committee to be inclusive and representative of wide-range of experience, expertise, ideas, and
unbiased prospective. Our GRC program committee is requesting supplemental funding ($10,000 budget),
specifically to support travel-related expenses for ten early-stage invited speakers of diverse background
(women and/or non-white) in the MCS field or related discipline. The primary goal of the GRC on Assisted
Circulation will be to address and achieve each of the following objectives: (1) identify best clinical practices
and provide inventive methods to achieve consensus and harmonize best practices among MCS centers and
health care providers; (2) review the latest advancements in novel MCS device technologies that represent
disruptive or revolutionary ideas in the field as well as highlight a "conceptual thinking" session, where GRC
participants can contribute to the development of novel device designs or innovative ways of problem solving;
and (3) highlight novel basic science discoveries and innovative methods to translate these discoveries into
best practices, including human biology and the changes and adaptation of the human biology associated with
the presence of MCS device therapy. GRC surveys will be completed by all attendees (invited speakers,
discussion leaders, participants) to assess program quality and whether objectives were successfully met, and
the program committee will complete a summary report highlighting critical areas of need and establishing Best
Practices criteria.

Public health relevance
Project Narrative – To address the current limitations of MCS therapy, the Gordon Research Conference (GRC) on Assisted Circulation provides a forum for clinical, engineering, and scientific communities from academia, government, hospitals, and industry come together to openly exchange and share data, technology, and clinical paradigms that lead to advances in the field of MCS therapy to improve patient outcomes and quality of life. The one-week GRC program provides an outstanding venue for promoting and facilitating multi- disciplinary, multi-institutional, and multi-diverse approaches to address these challenges by providing an extraordinary opportunity to collaboratively formulate effective solutions and establish Best Practices (clinical, engineering, science, regulatory). The primary goal of GRC is for these focused interactions to shift clinical paradigms, rapidly advance technology, ignite scientific breakthroughs, and seek regulatory guidance to accelerate clinical translation of safe and effective MCS therapy for HF patient population via).